NEUROCHEMICAL ANALYSIS FACILITY FOR TRANSMITTER RESEARCH

This equipment proposal seeks support for a facility dedicated to the analysis of neurotransmitter substances in the central and peripheral nervous systems. This facility would be used by basic neuroscience investigators in the Department of Anatomy at the University of Rochester School of Medicine and Dentistry. The equipment requested includes two high performance liquid chromatographic systems, both computer controlled and equipped with automatic sampling devices. Two different types of detectors are included: electrochemical detectors for analysis of catecholamines, indoleamines, and acetylcholine, and an ultraviolet detector for amino acids and peptides. This equipment, together with the necessary equipment for preparation of tissue samples will be housed together in a laboratory in the Department of Anatomy, forming a facility for the analysis of neurotransmitter substances necessary for research projects in areas of peptide-monoamine interactions, aging changes in peptide and monoamine neurons, central control of blood pressure and hypertension, monoamine systems in alcoholic rats, neural transplantation, and neural regulation of immune response. It will also provide a facility for broadening the training of graduate students and post-doctoral trainees in an area that complements and expands their anatomical studies.